Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core (AC)
In our currently active Translational Research Program in Colorectal Cancer Disparities (TRPCD) funded as a
P20 SPORE planning grant, the Administrative Core (AC) has built a strong foundation for collaborative research
via establishing partnerships with multiple institutions that has enabled us to evaluate colorectal cancer (CRC)
disparities across racial and ethnic groups who experience vastly different CRC incidence and mortality rates.
The AC of the TRPCD SPORE will support and integrate the activities of all research projects, the Biospecimen
and Pathology Core (BPC), the Biostatistics and Bioinformatics Core (BBC), the Career Enhancement Program
(CEP), and the Developmental Research Program (DRP) to maintain and grow our program in CRC disparities
research. Central to the AC's function is the coordination of efforts across the following entities:
1. All TRPCD investigators
2. Partnering institutions serving large numbers of racially and ethnically diverse cancer patients
3. Our Community Advisory Board (CAB), External Advisory Board (EAB), and Internal Advisory Board (IAB)
4. Review panels evaluating applications to the CEP and DRP
5. Representatives of the National Cancer Institute
6. New external partnerships built through this program including, but not limited to, those involving existing
SPOREs, other funded disparities programs, and commercial entities.
This Core has the following specific aims:
Aim 1. Leadership: To provide the organizational structure and scientific and administrative leadership needed
for the successful execution and evaluation of key TRPCD objectives.
Aim 2. Administrative Management: To provide administrative management of all SPORE components
including fiscal oversight, regulatory compliance, SPORE leadership succession plans, communication,
data management, and engagement with NCI.
Aim 3. Integration of the P50 Program with the host institutions: To coordinate TRPCD activities with
various projects, programs, and shared resources at partnering institutions such that integration of these
existing institutional resources will successfully support the TRCPD.
Aim 4. Planning and evaluation of SPORE activities: To plan SPORE activities, assist with and prepare
progress reports, organize regular CAB/EAB/IAB meetings, and support evaluations conducted by our
Advisory Boards.
Aim 5. Sustain collaborations: To develop and support multi-institutional intra- and inter-SPORE interactions
and initiate and sustain collaborations with key external partners.

Public health relevance
PROJECT NARRATIVE – Administrative Core (AC) The successful functioning of our Translational Research Program in Cancer Differences across Populations (TRPCDP) is highly dependent upon a capable and effective Administrative Core (AC). The AC will be vital for providing the requisite foundation for effective implementation of TRPCDP’s scientific and translational goals. This Core will provide overall leadership and administrative support, program management, incorporation with existing programs and shared resources, infrastructural support, communication within and across TRPCDP investigators and partnering institutions, and evaluation of all TRPCDP activities and components.